Spatial immunophenotyping of bacilli and secreted virulence factors in tuberculosis granulomas

PROJECT SUMMARY
Tuberculosis (TB) is caused by the pathogen Mycobacterium tuberculosis (Mtb) and its arsenal of secreted
virulence factors, exhibiting one of the largest global disease burdens caused by a single infectious agent. TB is
primarily a pulmonary disease with the latent form that affects 90% of infected individuals being asymptomatic,
while the active form is characterized by a spectrum of clinical findings ranging from mild to severe, including
cachexia, malaise, fever, and sputum production. A classic finding in the lungs of TB patients is the granuloma,
a microenvironment of host immune cells recruited to infection foci. While the granuloma is believed to be host-
protective by containing bacteria, concentrating immune responses, and preventing dissemination, granulomas
may be detrimental as a fibrotic niche that is impermeable to T cells, favorable for Mtb to lie dormant, and
impenetrable to antibiotics. These ineffective granulomas may contribute to latent TB in which true bacterial
sterilization is indiscernible, leaving the disease incurable and patients at risk for activation. The host-pathogen
interactions occurring within granulomas are thus important mechanistic targets for therapies but remain elusive.
While previous granuloma histopathology has resulted in extensive descriptions of host microenvironment, the
role of individual Mtb-expressed virulence factors in shaping these phenotypes has been underappreciated. This
proposal aims to stain granulomas from non-human primate (NHP) lungs and human lymph nodes with an
extensive panel of Mtb antigen-specific probes (i.e. commercial antibodies, novel in-house nanobody tetramers,
acid-fast staining, and RNAScope) and advanced host multiplexing techniques (i.e. Phenocycler) to elucidate
the localization, abundance, and molecular influence of Mtb factors on the granulomatous immune response and
its success. Preliminary data show that Mtb bacilli are phenotypically heterogenous in terms of virulence factor
expression, may localize far beyond the myeloid core where most bacilli reside, and secrete factors into host
cells across the infected lung. The central hypothesis is that Mtb differentially regulates its virulence factor
repertoire to manipulate immune dynamics, facilitating favorable granulomas that promote bacterial survival.
This fellowship proposal also outlines a training plan customized for refining a rigorous physician-scientist in lung
pathology and emerging/neglected infectious diseases. This includes an exceptional mentorship team with
expertise across histopathology and TB, experimental NHP cohorts, nanobodies, and other reagents/resources
unique to Oregon Health and Science University, and a training experience at the SAMRC Centre for TB
Research in endemic South Africa. Completion of this proposal will result in 1) understanding Mtb heterogeneity
in the infected lung, which may contribute to ineffective therapies and latent TB, 2) elucidating the role of virulence
factors in granuloma progression, and 3) identifying novel Mtb-host interactions as therapeutic targets.

Public health relevance
PROJECT NARRATIVE Despite significant efforts, tuberculosis (TB) remains one of the world’s most pervasive infectious diseases in part due to the persistence of Mycobacterium tuberculosis (Mtb) within lung immune structures called granulomas. Understanding how Mtb survives, evades immune clearance, and influences host responses within these granulomas is essential for developing more effective treatments. This project aims to advance the fields of TB and granuloma biology by investigating the spatial localization and phenotypic diversity of Mtb, as well as the role of secreted virulence factors in shaping immune responses in infected lungs and draining lymph nodes.